Industrial/Organizational Pathways to Helping Behaviors in Recovery Housing

DESCRIPTION (provided by applicant): This F31 study will examine a path model for the relationship of the congruence between people and their environment (P-E fit) to helping behaviors. This proposed model is derived from industrial/organizational (I/O) psychology literature. Substance abuse and dependence are common social health problems in the United States that are costly to both individuals and society. Although a variety of services have been developed to address these problems, high rates of substance use recidivism among service users are common. There is evidence that community-based addiction recovery support organizations such as sober-living houses contribute to positive abstinence outcomes. However, there is a need for research on the mechanisms related to these positive substance use outcomes, as well as ways to sustain and improve mutual-help recovery support organizations. Research has shown that individuals in recovery who engage in helping others have more positive substance use outcomes themselves. Research also suggests that helping behaviors in mutual- help groups may be important to maintaining both the therapeutic effect of groups on patient recovery and the vitality and survival of the group or organization itself. However, little research has examined factors that influence helping behaviors of mutual-help members. I/O research has found that satisfaction with and commitment to an organization are related to helping behaviors that occur within them. I/O research has also found that satisfaction and commitment are related to P-E fit - the greater the fit, the greater the satisfaction and commitment to the group/organization. One component of P-E fit that has been shown to be related to satisfaction is an organization's sufficiency in meeting member needs. I/O research has further found three components of fit to be related to commitment to organizations-incumbents' ability to meet the demands of the organization, congruence between personal and organization values, and the organization's sufficiency in meeting individual needs are all related to commitment to the organization. The proposed study will examine a path model for the relationship of these components of P-E fit to helping behaviors in a recovery home setting, with commitment to and satisfaction with the setting as mediators of that relationship. This study hypothesizes that the model will be a good fit for cross-sectional data collected from a nationwide sample (n=150) of mutual- help recovery home residents. The overall aim of this study is to explore the application of I/O theories of P-E fit to recovery home settings to better understand the factors that contribute to helping behaviors of residents.

Public health relevance
There is an extensive body of literature on mutual-help groups for addiction recovery but little research on factors that influence the success and survival of these groups, but one factor shown to be related to the success and maintenance of these groups and their members is member helping behavior (e.g. outreach, contributions to leadership, fundraising, and meeting attendance). Since little research has examined helping behaviors in mutual-help settings, the current study examines a path model of helping behaviors in mutual- support settings using industrial/organizational (I/O) theories of helping behavior and the congruence between persons and their environments (person-environment fit). These findings can inform recovery homes about factors that inhibit and foster helping behaviors to improve mutual-help addiction recovery home survival and resident recovery.